Molecular and physiological mechanisms of inner retinal remodeling

PROJECT SUMMARY
Retinal degeneration results in low vision and blindness by causing primary death of rods and cones and
secondary pathophysiological remodeling of inner retinal neurons. During remodeling, the retinal ganglion cells
(RGCs) -the only information output channel of the retina- become intrinsically hyperactive, decreasing the
signal-to-noise (SNR) ratio of remaining light responses (mid-degeneration), and of vision restoration
methodologies such as optogenetics (after degeneration). Together with layer-specific changes in gene
expression throughout the inner retina and reorganization of synaptic connections, remodeling is predicted to
dramatically affect the receptive fields and, therefore, corrupt the retinal circuits that are responsible for at least
40 known signal computations of visual information. However, elucidation of the mechanisms behind genetic,
morphological, and physiologically-driven circuit corruption is almost impossible without first identifying and
manipulating the root cause behind RGC remodeling. We have shown that upregulation and hyperactivation of
the retinoic acid receptor (RAR) is necessary and sufficient for degeneration-dependent spontaneous
hyperactivity. Inhibition of RAR -without rescuing the death of photoreceptors- results in decreased
hyperactivity, decompressed SNR, and improved contrast sensitivity and visual acuity in vivo. This not only
highlights the medical significance of this discovery, but also demonstrates that inner retinal computations are
essential for proper image-forming visual functionality. In this proposal, we seek to leverage this fundamental
breakthrough and our own expertise in the field to dissect the genetic, morphological and physiological events
that lead from RAR activation to neuronal remodeling, with the goal of mapping out the extent of circuit
corruption in distinct RGC populations, and to understand how these changes in the retina affect key
postsynaptic target areas of the downstream visual pathway. Preliminary data show that RAR’s downstream
target in Off-RGCs, the purinergic 2x isoform 7 receptor (P2X7), known to cause membrane hyperpermeability
in a RAR-dependent manner, is also necessary and sufficient to cause spontaneous and intrinsic neuronal
hyperactivity. However, the mechanisms that mediate between RAR upregulation and downstream activation
of P2X7, and the interaction between them and neuronal hyperexcitability, are unknown. We propose to study
the consequences of degeneration-dependent upregulation of the RAR-P2X7 signaling pathway in RGCs by
employing advanced methodologies and innovative technologies, pioneered by our lab and our collaborators.
Our expected results will aim to define crucial components in current and future strategies for visual
improvement and vision restoration in patients with photoreceptor dystrophies, such as preventing or reversing
retinal remodeling concomitantly with treatments aimed at slowing down the progression of degeneration or
restoring light responses. Beyond vision impairment, our results will tackle essential questions regarding the
mechanisms responsible for the extent and limitations of neuronal plasticity in sensory systems.

Public health relevance
PROJECT NARRATIVE Low vision and blindness occur when the photoreceptors (light-sensing cells of the retina) degenerate and die due to known or unknown causes. The rest of the retina (a.k.a. the ‘inner retina’) survives and remains connected to the brain, making this tissue and the cells in it, the only physical substrate available to improve or restore vision in these patients. The goal of our research is to understand how the surviving inner retina changes during and after photoreceptor degeneration, and whether these changes affect vision and reduce current and future treatments that are aimed at enhancing visual functionality in animal models that are affected by the same human diseases.